COMPUTATIONAL PHYSIOLOGY: FROM GENOME TO PHYSIOME

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Computational Physiology, satellite meeting to the IUPS 2005 congress (March 28-30, 2005, Catamaran Resort, San Diego, CA): Organized by Arzberger, McCulloch and Hunter. The meeting featured 24 speakers, and 57 participants, 24 of which also presented posters. The meeting was also sponsored in part by educational grants from technology and pharmaceutical companies such as IBM, Dell and Pfizer. http://nbcr.net/physiome/index.htm. Complete program is available at http://nbcr.net/physiome/program.pdf.